ACTG 343: THREE MAINTENANCE REGIMENS FOR HIV INFECTED SUBJECTS

This study will compare the proportion of subjects who sustain suppression of plasma HIV RNA to undetectable levels among the three regimens during the maintenance phase; evaluate the proportion of subjects who exhibit no resumption of HIV replication after therapy is withdrawn; to evaluate CD4 and HIV RNA levels at baseline and CD4 cell counts at time of randomization to the maintenance phase as a predictor of successful maintenance therapy; to evaluate the drug resistance of breakthrough isolates; and to evaluate kinetics of HIV RNA and proviral DNA doubling in subjects in whom viral replication increases after withdrawal of therapy.